Automated microscope platform with improved imaging and accurate neuron reconstruction capabilities for high-throughput studies of neuroregeneration

Project Summary/Abstract
The mammalian central nervous system typically fails to regenerate after injury, leading to incurable conditions
with immense healthcare burdens. An exception is a remarkable effect called lesion conditioning, where injury
to a neuron’s peripheral fiber activates cellular processes to greatly enhance neuroregeneration. Exploiting this
“conditioned” form of regeneration for therapy requires a clear understanding of its underlying mechanisms,
which is still lacking despite intense research in mammalian systems. Specifically, there is a knowledge gap
regarding the impact of neuron type, morphology, and connectivity on regeneration. An in vivo approach in the
worm C. elegans can reveal the cellular mechanisms underlying conditioned regeneration by femtosecond laser
surgery and high-precision microscopy of single neuronal fibers. Three genes identified in the worm also
modulate mammalian lesion conditioning, demonstrating that this approach can discover key conserved
mechanisms. Even though this approach is effective at examining single genes or mechanisms, its manual
execution precludes it from defining regenerative capacity across multiple neuron types and surgery locations.
Thus, there is a critical need to accelerate imaging and laser surgery to comprehensively study regeneration.
The overall objectives of the proposed project are to optimize an automated microscope platform and validate it
by broadly testing many neuron types in C. elegans for conditioned regeneration. The rationale for this project is
that an automated platform will permit large-scale regeneration studies that are currently impractical but required
to fully map regenerative pathways. The objectives will be achieved by the following Specific Aims: 1) Improve
image contrast to permit computer visualization of neurites. 2) Develop a real-time machine learning approach
for automated neuron reconstruction. 3) Assess regenerative capacity in a broad range of neuron types in C.
elegans. Work for Aim 1 will control the sample illumination and apply novel, real-time image processing to
improve the contrast between neurons and their background. In Aim 2, these improved images will be reversibly
compressed, computationally enhanced, reconstructed into a neuron model, and annotated for surgery. In Aim
3, the integrated platform will be used to perform surgery and reimage neurites in many neuron types in C.
elegans to examine the role of key genes in regeneration. Innovative aspects of the proposed project include:
an invertebrate model for lesion conditioning, new optical methods for improving imaging contrast, and novel
machine learning techniques for real-time neuronal reconstruction. The expected outcomes of the proposed
study are deep insights into the fundamental genetic and cellular mechanisms that determine the ability to
execute conditioned regeneration and the validation of an automated microscope platform for high throughput
imaging and surgery. These results are significant because they will establish important drivers of regeneration
in the central nervous system, including potential therapeutic targets that could effectively treat currently
incurable injuries and diseases of the nervous system.

Public health relevance
Project Narrative The proposed research is relevant to public health because it will accelerate the discovery of mechanisms that underlie regeneration in the central nervous system. A clear understanding of these mechanisms could enable the development of approaches to stimulate spinal cord healing and repair, dramatically improving medical outcomes and quality of life. Thus, the proposed research is relevant to the mission of NINDS that pertains to seeking fundamental knowledge about the nervous system for the purposes of reducing the burden of neurological disease.